The Effects of the Affordable Care Act Medicaid Expansion on Informal Care

Abstract
Over 70 percent of older adults aged 65 or older require assistance from caregivers with basic functions at
some point in their lifetime, and most of that care is provided informally by families and friends. These informal
caregivers, especially those to older adults with Alzheimer’s disease and Alzheimer’s disease-related
dementias (AD/ADRD), bear huge physical, phycological, and financial costs which limit their ability to provide
care. The most recent Medicaid expansion under the Patient Protection and Affordable Care Act (ACA-ME)
has been shown to substantially increase health insurance coverage and health care utilization, improve
enrollees’ physical and mental health and financial security, and influence their labor market outcomes. All
these effects could be potential mechanisms through which the ACA-ME impacts informal care. However,
despite the large number of studies on ACA-ME, little is known about its effects on informal care for older
adults. We propose to fill this gap by examining the effects of the ACA-ME on informal care provided to and
received by older adults. Specifically, we will use a difference-in-differences approach and compare informal
care provision and receipt among individuals living in states that expanded their Medicaid program before and
after the expansion relative to the change in informal care provision and receipt experienced by comparable
individuals living in non-expansion states over the same period. We will use the American Time Use Survey to
measure informal care provided by low-income adults aged 18 to 64 who are most likely to be affected by the
ACA-ME. We will use the Health Retirement Study to measure informal care received by older adults. By
considering this spillover effect of the ACA-ME on informal care, the proposed project will be important for
policymakers interested in designing more effective policies to sustain or even increase the supply of informal
care to meet the escalating demand and for those interested in a more comprehensive evaluation of the ACA-
ME.

Public health relevance
Narrative Demand for informal care provided by families and friends is increasing as the size and life expectancy of the older adult population and the costs of formal care continue to rise. The Medicaid expansion funded by the ACA (ACA-ME) could affect informal care provided to and received by older adults by alleviating the burdens on low-income non-elderly informal caregivers who are most likely to be affected by the ACA-ME. This project aims to analyze the effects of the ACA-ME on informal care provided to and received by older adults, including those with Alzheimer’s disease and Alzheimer’s disease-related dementias (AD/ADRD), and the findings will inform public health efforts to design more effective policies to sustain or even increase the supply of informal care and to have a more comprehensive evaluation of the ACA-ME.